Productive and latent HIV infection of microglia: virus and host wrestle for SUMOylation system control

Contact PD/PI: LANGFORD, T. DIANNE
PROJECT SUMMARY
This project will explore strategies to target epigenetic pathways for achieving sustained HIV remission
and treatment of HIV associated-central nervous system (CNS) dysfunction. The conjugation of small ubiquitin-
SUMO proteins to substrates is a well-described post-translational modification that regulates protein activity,
subcellular localization, and protein-protein interactions for various downstream activities. SUMO proteins are
also important in anti-viral immunity, opposing viral replication and mediating interferon-dependent anti-viral
mechanisms. Thus, pathogens have evolved to exploit the host SUMOylation machinery to ensure viral
persistence and pathogenesis. During infection, the human immunodeficiency virus type 1 (HIV-1) manipulates
the host SUMOylation machinery to ensure its viral replication in CD4+
manipulates
Microglia
T cells, however, whether HIV-1
the SUMO paralogs to control its replication and/or atency in glial cells like microglia is unclear.
are the main HIV-1 target cells in the CNS and constitute an important reservoir for viral pathogenesis.
l
In microglial cells, the co-repressor COUP-TF interacting protein 2 (CTIP2) recruits a multi-enzymatic chromatin-
modifying complex and establishes a heterochromatic environment at the HIV-1 promoter, leading to HIV-1
silencing. Studies have shown that post-translational modifications (PTMs), including phosphorylation and
SUMOylation, mediate CTIP2's interactions with other proteins and complexes. Similarly, tripartite motif-
containing protein 28 (TRIM28), a known SUMO E3 ligase, associates with CTIP2 in the heterochromatin
complex to inhibit HIV-1 viral replication. While
regulating
respectively,
unknown.
productive
SUMOylation
inducible
SUMOylation and phosphorylation have been implicated in
the activity of CTIP2 and TRIM28 in the context of T-cell signaling events and immune responses,
the impact of PTMs in the initiation and establishment of HIV-1 latency in microglia remains
To this end, this proposal's central hypothesis is that the host SUMOylation system is i mpaired during
HIV-1 infection in microglia and that latency is established as a result of the estoration of
of host proteins. To test this hypothesis , we will use immortalized human microglial cell lines and
pluripotent stem cells (iPSCs), including a novel model of HIV-1 latency.
r
We will also identify the
SUMO-modified proteome of human microglial cells during human HIV-1 infection.
Project Summary/Abstract

Public health relevance
Contact PD/PI: LANGFORD, T. DIANNE PROJECT NARRATIVE proposed the host for host SUMOylation system i s a dynamic process t hat is highly responsive to viral infections. The research will nvestigate how the host SUMOylation system responds to HIV-1 infection in microglia, l argest reservoir for HIV-1 in the central nervous system (CNS). This work wil l therefore describe how the SUMOylation system is altered during productive and latent HIV-1 infection, providing critical information the development of therapeutics that may serve as novel targets in either “shock-and-kill” or “block-and-lock” The i strategies. Project Narrative